Health and Safety Training CoPilot: An AI-Driven Pre-Training Generator Tool Benefiting Low-Literacy and Limited-English Workers

Summary/Abstract
The Health and Safety Training CoPilot project addresses a critical gap in workplace safety training for
low-literacy and limited-English proficiency workers, who often face significant barriers in understanding
complex safety protocols and regulations. With approximately 32 million workers exposed to hazardous
materials, the need for clear, accessible training is paramount to reduce workplace incidents and ensure
compliance with safety standards. Traditional training methods frequently fail to meet the diverse needs of this
population, leading to increased risks and inadequate hazard awareness.
This innovative project leverages advanced AI technologies to create a cloud-based platform that generates
adaptive pre-training materials tailored to the unique needs of workers. By utilizing a curated database of
trusted health and safety resources, including OSHA and NIOSH guidelines, the CoPilot will provide
personalized content that enhances comprehension and retention. The integration of multilingual support and
reading level algorithms will ensure that training materials are accessible to all workers, fostering a safer work
environment.
The workplan involves three specific aims: curating and preprocessing trusted sources, developing an adaptive
learning engine for personalized content generation, and validating the system with stakeholder feedback.
Through iterative testing and collaboration with public health experts, the project will refine its approach to
effectively meet the training needs of diverse worker populations.

Public health relevance
Narrative The Health and Safety Training CoPilot project will develop an AI-driven platform that generates adaptive pre-training materials tailored for low-literacy and limited-English proficiency workers. By curating trusted health and safety resources and implementing algorithms for reading level adjustments and language localization, the platform significantly improved comprehension and engagement among diverse worker populations. We believe stakeholder feedback and iterative testing validating the effectiveness of the training materials will demonstrate a marked enhancement in workplace safety training, awareness and compliance.